Training in theoretical and computational approaches to neural circuits of cognition

Through a coordinated program of research, mentoring, coursework, and partnerships, we will
train a cohort of students and postdoctoral fellows who will become leaders in interdisciplinary,
computational research that advances central questions in the cellular and circuit basis of
cognition. We will foster a community of trainees equipped with a skillset that unites
fundamentals of neurobiology, mathematics, scientific computing, and equips them to engage in
real dialogue and innovation across fields using collaborative and reproducible approaches. The
projects undertaken by trainees in this research program will directly address key questions
relevant to the NIH's mission including: the study and advancement of theoretical and
computational models that describe how information processing arises from dynamics of
neurons and their networks, the study and advancement of the analysis of multi-modal, high-
dimensional neural data, and the investigation of complex neural circuit dynamics and function
in health and disease. Each trainee will receive joint research mentorship between a leading
computational and experimental neuroscientist at UW, thus gaining the skills and experience to
ensure that their computational work occurs within a virtuous cycle that allows theory to further
drive novel experiments. We will expand the scope of the computational neuroscience
community by recruiting from underrepresented groups, building bridges across departments
and schools, and connecting trainees with emerging opportunities within and beyond academia.
We will admit up to three students and two new postdoctoral fellows each year for a two-year
period, training up to 13 students and 9 new postdocs in total over the course of the program.
Trainees will have backgrounds in the computational, biological, and mathematical sciences.

Public health relevance
New technologies are revealing an unprecedented view of patterns of brain activity and brain connectivity. These data are extraordinarily complex, and computational and theoretical methods to analyze and interpret them lag far behind. Our training program will provide students and postdoctoral trainees with mentored training that connects computation and experiment with the skills to bridge fields using collaborative and reproducible analytical approaches.